Career Enhancement Program (CEP)

SUMMARY: CAREER ENHANCEMENT PROGRAM
The Career Enhancement Program (CEP) is designed to provide training and guidance for academic physician-
scientists, clinician-investigators, and laboratory-based scientists who wish to dedicate their efforts to improving
the diagnosis and treatment of brain tumors through translational research.
In order to meet this goal, the CEP has developed these specific objectives:
 Recruit and train physicians, scientists, and senior post-doctoral fellows to become outstanding
translational investigators in the field of neuro-oncology;
 Educate awardees in the basic principles of brain tumor biology, at both the molecular and cellular level,
with an emphasis on translational science;
 Provide awardees with a firm foundation in laboratory, clinical, and epidemiologic principles of brain
tumors;
 Guide awardees through the logic and process of developing sound translational studies that integrate
relevant laboratory, clinical, and epidemiologic findings to provide the basis for their development as
effective translational brain tumor researchers.
We will achieve these objectives through a strong mentorship program in which awardees are instructed in the
clinical and epidemiological principles of brain cancer, combined with basic science studies of cell biology,
molecular genetics, and cancer biology. The CEP will recruit senior clinical or laboratory-based post-doctoral
fellows and junior faculty who wish to develop a career in translational research focused on brain tumors. In
addition, established senior faculty who wish to re-direct or extend their ongoing research programs will be
eligible for participation.

Public health relevance
NARRATIVE: CAREER ENHANCEMENT PROGRAM (CEP) The Career Enhancement Program (CEP) fosters the scientific development of junior investigators who intend to focus their careers on translational studies of brain tumors.